Revealing the Mechanisms and Physiology of Peroxisome Transfer in Stem Cell Therapy

Project Summary (Abstract). Cell-to-cell communication is important in all tissues and organs and occurs by a variety of mechanisms. Cytokine secretion, gap junction proteins, small molecules, and exosomes have been shown to facilitate the exchange of cytoplasmic “information” between cells. Another novel mode of cellular communication is that of organelle transfer which has been shown to occur with mitochondria. Peroxisomes are small lipid bound organelles which are responsible for the metabolism of very long chain fatty acids in the cell. There are several rare, but devastating childhood diseases that are a result of peroxisomal defects such adrenoleukodystrophy (ALD). We have new evidence that peroxisomes can be transferred between cell types. We hypothesize that peroxisomal transfer could be a mechanism that allows for the stabilization of cells harboring dysfunctional peroxisomes. The goal of this application is to develop an animal model in which peroxisomes are labeled within hematopoietic cells to allow adoptive transfer experiments and observation of peroxisomal transport in vitro and in vivo. Aim 1: Optimize the zebrafish model of peroxisomal transfer. Our pilot data, generated in a zebrafish model of hematopoietic transplant, indicate that donor cells can transfer peroxisomes to recipient hematopoietic cells. It would be ideal to understand if we can fully optimize this system in terms of cell dose and time after HCT. We will determine the optimal conditions for peroxisome transfer to occur in this model by varying the cell doses and time after transplant readout. Transfer will be determined by flow cytometry and verified by cell sorting and fluorescent microscopy. Aim 2: Study the in vitro phenomenon of peroxisomal transfer between various cell types and monitor changes in cellular function. We have created a variety of cell lines and have primary cells with GFP containing a peroxisome tag sequence (PTS-GFP) which allows for specific peroxisome labeling. We will perform co-culture experiments to observe peroxisomal transfer and will quantify the physiological effects of transferring healthy peroxisomes into cells with dysfunctional peroxisomes measuring reactive oxygen species and mitochondrial function. Aim 3: Generation of a PTS-GFP expressing mouse under the control of the Rosa locus. The goal of this aim is the establishment of a colony of PTS-GFP transgenic mice to be used as donors or recipients in adoptive experiments allowing us to determine if peroxisomal transfer occurs in vivo. HSPC from donor mice will transplanted into wild-type mice. PTS-GFP mice can also be used as recipients to determine if cells of the marrow niche can transfer peroxisomes into unlabeled donor cells. This project carries both high risk and high reward, as its success will open an entirely new field and thought process into peroxisomes, organelle transfer, and cellular communication. We will gain new knowledge and build tools to not only better understand peroxisomal transfer, but develop new strategies, drugs, and small molecules to enhance the process which could impact how we treated devastating peroxisomal disease like ALD.

Public health relevance
Peroxisomal disorders have their onset in early childhood, with profound morbidity and often lead to death in the first decade of life. Understanding if peroxisomes can be transferred from healthy cells to diseased cells has important consequences for the field of cell biology, and also would also lead to novel therapies for children with peroxisomal disorders.